Cardiovascular Epidemiology Training Grant

ABSTRACT
This competing continuation application builds on nine successful five-year cycles of
NRSA/NHLBI supported academic and applied research training in cardiovascular (CV)
epidemiology at the Department of Epidemiology, University of North Carolina (UNC), Gillings
School of Global Public Health. The program's goal is to train effective and independent
researchers in the disciplines and methods intersecting CV epidemiology, in order to channel
qualified scientists into a diversified workforce capable of addressing the national burden of
CVD. Historical strengths of the program include excellence in training and mentoring, trainee
productivity, successful transitions to careers in science, and the recruitment and support of
trainees from groups underrepresented in the sciences. This program has actively pursued
strategic innovation and ongoing improvements to better prepare population scientists and keep
our program salient and effective. New elements to the be added in this continuation application
include an external Distinguished Alumni Council, and expanded training and research
opportunities in data and information science as an additional area of research emphasis.
Of the 43 pre-doctoral and post-doctoral trainees completing their degree program or
postdoctoral fellowships over the past 15 years, 27 (63%) currently hold faculty positions at
major research universities. Overall, 40 (93%) of trainees over the last 15 years currently hold
research positions in either academics, federal movement or private industry. The 15 trainees in
the program during this cycle published 72 peer reviewed manuscripts, nearly half (49%) of
which as first authors. Of the 15 individuals appointed in the current cycle, 4 are in groups
underrepresented in biomedical sciences. Of the 10 trainees currently in the program, 3 are
from underrepresented groups.
The program's leadership and support structure include a program steering committee, an
external advisory body of Distinguished Alumni, and trainee support teams. Distinctive features
of the program are effective mentorship, career development planning, modular curriculum
structure, on-going peer-led workshops, interdisciplinary seminar series, faculty and trainee-led
journal club, research practica and breadth of research collaboration opportunities. The program
enjoys strong institutional support. The program also conducts careful evaluation by the trainees
and faculty of the effectiveness of the program and its productivity. As part of this application,
we request funding for five predoctoral and three postdoctoral trainee positions.

Public health relevance
Project Narrative By continuing to innovate in active learning, engaged mentoring, dynamic research areas, and ongoing self-assessment the Cardiovascular (CV) Epidemiology Training Program at the University of North Carolina seeks to train effective and independent researchers in the disciplines and methods intersecting CV epidemiology. The proposed plan builds on historical strengths of the program and introduces new initiatives to strengthen the training experience. The program's trainees and alumni are exceptionally productive and successful researchers and scholars making important contributions to the field.